DCP- Cancer Immunoprevention Laboratory Support

Establish a new Cancer Immunoprevention Laboratory ? Dedicated to DCP and serve as a reference lab confirming key results from Task order contractors using standardize methods and performing work to advance successful immunoprevention concepts in preclinical development.